Characterization of aneuploidy, cell fate and mosaicism in early development

PROJECT SUMMARY
The presence of aneuploidy (chromosomal abnormalities) in embryos is considered one of the major limitations
to successful human reproduction and a significant cause of gestation failure, accounting for approximately 50%
of early miscarriages. Aneuploidy rates are strikingly high in in vitro fertilized human embryos, and around 60%
of these embryos are mosaic, containing both aneuploid and normal euploid cells. The frequent occurrence of
mosaicism exists in both naturally conceived and IVF pregnancies. However, despite the high incidence of
aneuploidy in human embryos, our knowledge of the molecular mechanisms and developmental fate of these
cells is restricted due to the considerable ethical limitations associated with human embryo and fetal research.
My previous work demonstrated lineage-specific behavior of aneuploidy in early differentiation using an in vitro
human embryonic stem cell (hESC) model. To further characterize the cellular physiology of aneuploidy after
implantation, an in vivo animal model is required. Common marmosets exhibit naturally occurring aneuploidy,
making them a more representative model for humans than rodents are. Therefore, I propose a marmoset model
to further dissect aneuploidy cell fate and its molecular and cellular consequences during early development. My
preliminary data uncovered that aneuploid marmoset embryonic stem cells (cj-ESCs) preferentially differentiate
into trophectoderm lineages in response to BMP4 stimulation, similar to the behavior I observed with hESCs in
my previous work, suggesting a conserved role of aneuploidy in restricting stem cells to extraembryonic fates.
During the training period, I will use a unique marmoset stem cell model (gastruloid) that recapitulates early
lineage specification and gastrulation to investigate the role of BMP4 signaling in the phenotypic manifestation
of aneuploidy (Aim 1). To further investigate the elimination and allocation of aneuploidy, I will construct mosaic
marmoset embryos to probe aneuploidy cell fate and behaviors during pre-and post-implantation embryonic
development in vitro (Aim 2). Since my preliminary data indicates a higher tolerance of aneuploidy in the
extraembryonic lineages, during the independent phase of the award period, I propose to analyze the gene
expression profile of aneuploidy in the marmoset placenta to understand the effects of aneuploidy on the cellular
physiology of extraembryonic tissue. In addition, during this phase, I will construct a placental/trophoblast
organoid from cj-ESCs to further dissect the behaviors of aneuploidy in different placental lineages (Aim 3).
Together, the proposed research will present a comprehensive model for studying a previously uncharacterized
mechanism underlying the elimination of aneuploidy during embryogenesis, paving the way for translational
applications to assisted reproductive technologies. The proposed project will also serve as a platform for me to
obtain training and scientific expertise in molecular and developmental biology, animal reproductive sciences,
and computational genomics which will contribute significantly to my career development as an independent
investigator in the field of reproductive biology.

Public health relevance
PROJECT NARRATIVE The presence of aneuploidy (chromosomal abnormalities) in embryos is considered one of the major limitations to successful human reproduction and a significant cause of gestation failure, accounting for approximately 50% of early miscarriages. Despite the high incidence of aneuploidy in human embryos, our knowledge of the developmental fate of these cells and the involved molecular is restricted due to the considerable ethical limitations associated with human embryo and fetal research. The proposed study aims to establish a comprehensive marmoset model to examine aneuploidy cell fate and the putative elimination mechanism accompanying mosaicism during embryonic development, with the ultimate goal of providing the knowledge necessary for improving pregnancy success.